Multifunctional siRNA/antibody nanocarriers to treat metastatic triple-negative breast cancer

PROJECT SUMMARY/ABSTRACT
Triple-negative breast cancer (TNBC) is an aggressive disease that grows quickly and metastasizes early.
There are no effective therapies for metastatic TNBC, so new strategies are needed. We will meet this need
using nanoparticles (NPs) we developed that interfere with Wnt signaling, the key driving force behind TNBC
growth and metastasis. The main effector of Wnt signaling is β-catenin, and it is activated in TNBC cells when
wnt ligands bind frizzled7 (FZD7) receptors that are overexpressed on TNBC cells relative to normal cells.
Active β-catenin promotes TNBC growth and metastasis by amplifying the expression of genes that support
cell survival, proliferation, stem-like behavior, migration, and invasion. Our central hypothesis is that
suppressing Wnt signaling at two levels will reduce TNBC cells’ metastatic potential, so we have created Wnt
inhibitory NPs coated with both FZD7 antibodies and β-catenin small interfering RNAs (siRNAs) to accomplish
this task. The FZD7 antibodies enable TNBC cell binding and prevent Wnt signaling from being activated by
blocking wnt ligands from binding FZD7. The siRNAs further suppress Wnt signaling by directly inhibiting β-
catenin through RNA interference. Our preliminary studies indicate that these NPs can enter existing TNBC
lung metastases in mouse models to inhibit their growth. In the proposed work we will elucidate the
mechanism of action of these NPs in greater detail by studying their interaction with TNBC cells in vitro (Aim
1), validate that they can penetrate existing metastases in mice to halt their growth (Aim 2), and show that they
can safely prevent the formation of new metastases in immune competent tumor-bearing mice (Aim 3). All
aims will compare NPs that co-deliver FZD7 antibodies and β-catenin siRNAs to NPs that deliver either agent
individually in order to reveal if their combined effects are additive or synergistic. In addition to studying the
NPs’ impact on TNBC cells, we will also evaluate their effect on non-cancerous cells from breast, lung, and
bone tissue in order to confirm they have negligible off-target effects. We will further study their safety in Aim 3
by monitoring animal weight, blood chemistry, and major organ histopathology. We expect to find that these
NPs can inhibit Wnt signaling in TNBC cells to reduce their metastatic potential without impacting non-
cancerous cells, enabling them to be used as tools to either treat existing metastases or prevent formation of
new metastases. We also expect for NPs that co-deliver FZD7 antibodies and β-catenin siRNAs to be more
effective than NPs that deliver either agent individually. In summary, this project will evaluate Wnt inhibitory
NPs as tools to treat and/or prevent TNBC metastasis. Unlike current therapies, which have unpredictable and
insufficient results, our NPs will directly target TNBC cells and reduce their ability to grow and metastasize by
suppressing Wnt signaling. If successful, this therapy will improve survival and quality of life for patients with
metastatic TNBC, and it may ultimately be expanded to other cancers with different molecular drivers by
altering the antibodies and siRNAs that are delivered with the NPs.

Public health relevance
PROJECT NARRATIVE Triple-negative breast cancer, which accounts for 15-20% of breast cancer cases, has higher metastasis rates and lower survival rates than other breast cancer subtypes because it is unsusceptible to available hormonal or targeted therapies. The proposed studies will demonstrate the capacity of a new nanoparticle-based gene regulatory agent we developed to treat and/or prevent triple-negative breast cancer metastasis by decreasing the expression of genes that promote its aggressive growth and distant spread. The results generated will not only validate a new technology for treating triple-negative breast cancer, but also yield substantial new insight to nanoparticle/biological interactions that may guide future development of improved treatments for various forms of cancer.